Novel ultrahigh speed swept source OCT angiography methods in diabetic retinopathy

Diabetic retinopathy (DR) is a leading cause of blindness in working age populations. Glycemic control remains
the best strategy for preventing or slowing disease progression. However, early detection of vision threatening
retinal changes and prompt treatment is necessary for preserving visual function in more advanced stages.
Clinical management of DR also requires objective tools for assessing retinal structure and microvascular
abnormalities, as well as methods to evaluate treatment response. The goal of this multidisciplinary program is
to develop novel optical coherence tomography (OCT) imaging methods and biomarkers that can identify and
characterize retinal microvasculature and blood flow alterations in DR, which can be used for early disease
detection, predicting progression, monitoring treatment response, and improving clinical trial efficiency. We will
develop next generation OCT angiography (OCTA) technology and analysis frameworks (Aim 1). This hardware-
software innovation will develop ultrahigh speed swept-source OCT (SS-OCT) to enable increased dynamic
range OCTA characterization of retinal blood flow, higher definition volumetric data to visualize vasculature at
the capillary level, and enable wide field structural and vascular imaging. These advances will develop a
quantitative surrogate marker for capillary level blood flow speeds in retinal microvasculature. The ability to
assess blood flow speeds at the capillary level represents a paradigm shift in OCTA imaging, enabling detection
of subtle vascular flow alterations that occur at earlier disease stages, which are related to pathogenesis of
diabetic macular edema (DME), capillary non-perfusion and neovascularization. New software motion correction
technology can correct volumetric OCT/OCTA data for eye motion in three dimensions and artificial intelligence
/ deep learning techniques can generate reliable layer segmentations for OCTA, to facilitate tracking longitudinal
changes across multiple patient visits. Using ultrahigh speed SS-OCT and OCTA blood flow biomarkers, we will
perform a cross-sectional study in a cohort of diabetic patients and age-matched healthy controls (Aim 2). The
study will evaluate repeatability of OCTA-driven VISTA flow markers, investigate if OCTA blood flow biomarkers
are correlated with DR severity, and if they are associated with DME, capillary non-perfusion or
neovascularization. Finally, we will monitor DR eyes longitudinally to investigate the role of subtle blood flow
alterations in disease progression and predicting treatment response (Aim 3). The hypothesis is that OCTA blood
flow biomarkers can identify regions with abnormal blood flow, which are at increased risk of thrombosis and
leakage, and hence DME, as well as regions that are ischemic, and at increased risk of neovascularization.
Similarly, we will also investigate if OCTA blood flow biomarkers can be used to predict response to anti-VEGF
(vascular endothelial growth factor) therapy, including DME resolution, neovascular regression, and/or treatment
durability. If successful, this program has the potential to improve clinical DR management and help DR patients
to achieve better vision outcomes.

Public health relevance
This multidisciplinary program aims to develop next generation optical coherence tomography (OCT) methods and new imaging biomarkers of retinal microvascular and relative blood flow speeds at the capillary level for understanding and managing diabetic retinopathy (DR). The proposed studies address impactful questions related to clinical DR management, including early disease detection, predicting risk, monitoring disease progression and treatment response, and improving clinical trial efficiency. The long term goal is to create an imaging based tool to guide medical intervention and accelerate drug development, which can lead to better preservation of visual function in DR patients.